ANTIBIOTIC TREATMENT OF GRAM POSITIVE BACTERIURIA IN SYSTEMIC DISEASE

A study testing the hypothesis that the primary stimulating antigen of some autoimmune disease is derived from bacteria and that the course of the disease can be altered by their elimination.